Effects of Acute Exercise on Functional Magnetic Resonance Spectroscopy Measures of GABA in Aging and Chronic Stroke

The current proposal seeks to index the effect of acute aerobic exercise on excitatory and inhibitory balance using
magnetic resonance spectroscopy (MRS) in aging and in chronic stroke. There exists replicated evidence that
acute bouts of aerobic exercise increase sensorimotor gamma-aminobutyric acid (GABA) within a two-hour
period. Our lab has the technical capability to reliably measure GABA between two sessions and we have
developed a functional measure of motor learning that alters GABA in older adults called functional MRS (fMRS).
Focal increases in SM GABA due to acute exercise offers the opportunity to test the hypothesis that aging related
decreases in motor learning may be related to lower levels of SM GABA. That is, GABA levels may need to increase
to a specific level before selective release of SM GABA can afford improved long-term potentiation. This can be
evaluated using a cross-sectional approach. However, to date, we have not employed an acute exercise model
within our lab for functional MRS. This study will evaluate the feasibility of this approach. Further, as the intent
of our research program is to translate aging-related findings to stroke motor rehabilitation, we will use this
SPiRE to directly study stroke patients with chronic upper extremity impairment. In light of early findings from
a current Merit Award, we now seek to pilot MRS measures in SM in chronic stroke survivors to measure changes
in GABA after a bout of acute exercise. To achieve these goals, we will enroll 30 participants in cross-section to
test if acute aerobic exercise can have immediate modulatory effects on levels of SM GABA as these relate to
motor learning. As these aims involve evaluating the feasibility of a new intervention with two populations (aging
Veterans and those with chronic stroke), we believe this offers high impact for motor rehabilitation.

Public health relevance
Rehabilitation of upper extremity dysfunction after stroke is time-intensive and involves highly variable behavioral outcomes. Recently discovered aging-related changes in the activity of the neurotransmitter gamma- aminobutyric acid (GABA) may inform motor outcome variability and act as a potential biomarker of motor learning capacity. GABA levels in the cortex can be measured using magnetic resonance spectroscopy (MRS). Recent studies have shown that GABA is reduced in the aging brain and after chronic stroke in the ipsilesional cortex. Acute bouts of aerobic exercise increase levels of GABA in sensorimotor regions (SM) and improve motor learning in younger adults. However, it is currently unknown how bouts of acute exercise modify GABA levels: a) in the aging brain and b) in patients with chronic stroke. This pilot proposal will test how acute exercise changes levels of GABA as assessed by MRS in relation to motor learning performance in older adults and a small cohort of patients with chronic upper extremity hemiplegia after stroke.